Regeneration of Thalamopallial Projections and Sensory Function in the Salamander Brain

Project Summary
The pallium is a signiﬁcant vertebrate brain division that includes the mammalian cerebral cortex. In
salamanders, the pallium exhibits a remarkable ability to regenerate neurons, making this a valuable model to
understand how function can be restored in injured brains. Although pallial neurons can regenerate, we do not
know if synaptic inputs to the regenerated pallium are restored. The project uses whole brain light sheet
microscopy to examine whether inputs to the pallium from the thalamus are restored after a large pallial lesion.
The ﬁrst aim in this proposal will map and compare thalamopallial projections in the uninjured and regenerated
pallium. These experiments will demonstrate whether the regenerated pallium is re-innervated by thalamic
axons following pallial lesion. The second aim describe the regionalized activity of pallial neurons in response
to thalamic sensory stimuli. These experiments will determine whether regionalized sensory activity returns in
the regenerated pallial area. This research project will support the fellow's development of skills that include
image analysis, neuron tracing, and scientiﬁc communication.

Public health relevance
Project Narra+ve This project examines the extent to which thalamic inputs to the pallium are restored in the regenerated salamander brain. This work will shed light on the capacity or limita:ons of brain regenera:on in vertebrates that could inform future interven:ons for brain diseases in humans.